Linking metabolite sensing and gene expression in malaria parasites

Malaria is a life-threatening disease that is transmitted to humans by the bite of Anopheline mosquitoes infected
with Plasmodium parasites. Proliferation of parasites within erythrocytes in the bloodstream is central to the
parasite’s survival and results in the pathogenesis of malaria. Little is known about how the metabolic
environment of the parasite is sensed and linked to changes in gene expression. One of the major factors
underlying severe malaria, caused by infection with Plasmodium falciparum, is lactic acidosis, which has a
complex etiology, with lactate being produced by both the parasite and the host. During the asexual stages, P.
falciparum parasites carry out fermentative glycolysis leading to the conversion of pyruvate into lactate. In
addition, the host, due to aerobic glycolysis in proliferating immune cells and anaerobic glycolysis in hypoxic
cells, contributes to increased lactate levels in the bloodstream. In vitro studies have shown that the parasite
responds to changes in host lactate levels. Lactate accumulation can retard parasite growth, alter the rate of
switching to transmissible forms, and has been associated with virulence gene expression. However, the
mechanism underlying these profound changes in parasite phenotypes is unknown. In a recent study, a new
post-translational modification (PTM), lactylation, was reported in human and mouse cells, that responds to
lactate levels. In mammalian cells, several hundred proteins including histones are lactylated, and increased
lactate levels in the course of a bacterial infection resulted in gene expression changes in macrophages,
providing a link between cellular metabolism and gene expression. We have discovered this new PTM on the
tails of multiple histones in P. falciparum. We hypothesize that lactate-derived lactylation of parasite histones is
a novel histone code signature that mediates gene expression changes linked to lactate metabolism. We will
comprehensively assess histone lactylation dynamics through the parasite asexual cycle as well as the ability of
histone lactylation to be altered by perturbations in lactate metabolism. These investigations will be performed
both in a diverse panel of laboratory strains, as well as patient isolates with different disease severity. We will
also identify the target genes of histone lactylation and their association with transcriptional programs linked to
parasite cellular processes. The findings from this proposed work have the potential to establish a critical role
for histone lactylation at the fulcrum between lactate metabolism and gene expression in asexual stages of P.
falciparum, with significant implications for malaria pathogenesis and transmission.

Public health relevance
The proliferation of the malaria parasite, Plasmodium falciparum, within the red blood cell is central for the parasite’s survival and transmission, and may be altered in response to host metabolites, such as changes in host lactate levels. We have discovered that a new post-translational modification of proteins, lactylation, is found on histone tails of P. falciparum, proteins that can influence the expression of specific sets of genes. In this proposal, we will assess the ability of histone lactylation to act as a code linking changes in lactate metabolism to gene expression underlying the pathogenesis of P. falciparum parasites.